Characterizing the relationship between medical mistrust, health behaviors and neighborhood level factors in African American cancer survivors.

Project Summary
African Americans experience an unequal cancer burden, with the highest incidence and
mortality rates for most cancer types. For African American cancer survivors, this burden
continues posttreatment as evidenced by reports of poor related quality of life scores. Medical
mistrust, the belief that healthcare providers, institutions and systems at large do not have an
individual’s best interests in mind, is an understudied potential cause of cancer health
disparities. When considering the impact of medical mistrust, it is even more important to
consider group-based medical mistrust, which includes both an interpersonal and vicarious
examination of healthcare experiences to further tease out the nuance of this phenomenon. The
proposed diversity supplement aims to characterize the relationship between medical mistrust,
survivorship outcomes, in the context of neighborhood level factors to better understand the
experiences of African American cancer survivors. We will investigate the relationship between
health behaviors and survivorship outcomes. After which we will investigate whether the
neighborhood level factors mediate the relationship between medical mistrust and survivorship
outcomes, or medical mistrust is moderated by neighborhood level factors. Finally, we will host
several focus groups with past participants using member checking to allow participants the
opportunity to offer feedback and commentary on the medical mistrust results.

Public health relevance
Project Narrative This project aims to describe the relationship between medical mistrust, health behaviors and health outcomes, in the context of the neighborhood environment in African American cancer survivors. The purpose of this is to better understand how medical mistrust impacts African American cancer survivors to begin developing multilevel interventions.